LRRK2 Enzymatic Mechanisms of Neurodegeneration in Parkinson's Disease

Project Summary
Parkinson's disease (PD) is a progressive neurodegenerative movement disorder caused primarily by the
degeneration of dopaminergic neurons in the substantia nigra. Mutations in the leucine-rich repeat kinase 2
(LRRK2) gene cause late-onset, autosomal dominant PD, and LRRK2 coding and non-coding variants are
associated with risk of sporadic PD. LRRK2 has emerged has an important therapeutic target for treating PD
and therefore it is critical to understand the key mechanisms underlying disease-linked mutations. LRRK2 is a
large multi-domain protein containing Ras-of-Complex (Roc) GTPase and protein kinase enzymatic domains
separated by a C-terminal-of-Roc (COR) domain. GTP-binding via the Roc domain is critical for normal kinase
activity. Familial LRRK2 mutations cluster within the Roc (R1441C/G/H), COR (Y1699C) and kinase (G2019S,
I2020T) domains where they commonly enhance the phosphorylation of a subset of Rab GTPase substrates in
cells. Roc-COR domain mutations act indirectly on kinase activity by impairing GTP hydrolysis and promoting
the GTP-bound `on' state. The GTPase and kinase domains represent promising targets for inhibiting LRRK2.
While familial LRRK2 mutations share the capacity to induce neuronal damage in cultured cells, their effects in
animal models are less certain due to a lack of robust neurodegenerative phenotypes. In addition, how the two
enzymatic activities contribute to neuronal damage in vivo induced by familial LRRK2 mutations is poorly
understood. We have recently developed an adenoviral-mediated gene transfer model in adult rats where
G2019S LRRK2 induces nigrostriatal pathway dopaminergic neurodegeneration through a kinase-dependent
mechanism. In the present application, we propose to exploit this robust and rapid rodent model to determine
whether kinase activity is commonly required for neurodegeneration induced by familial mutations (R1441C,
Y1699C and G2019S) or PD risk variants (G2385R) in LRRK2 by genetic and pharmacological kinase inhibition
(Aim 1.1). The contribution of Rab phosphorylation to neuronal damage induced by mutant LRRK2 is not known.
We will determine the neuroprotective effects of globally reducing Rab phosphorylation in mutant LRRK2
neuronal and adenoviral rat models by overexpressing a novel Rab-specific phosphatase, PPM1H (Aim 1.2).
Knockdown of PPM1H will explore whether increasing Rab phosphorylation is sufficient to phenocopy the
neurotoxic effects of mutant LRRK2. Our studies will further explore whether genetically modulating GTPase
activity can provide a common neuroprotective mechanism against different familial LRRK2 mutations in rodents
(Aim 2.1). In particular, we will evaluate hypothesis-testing mutations that increase GTP hydrolysis and promote
the GDP-bound `off' state of LRRK2. Finally, we will explore how the native interactome of LRRK2 in neurons is
regulated by the GTPase cycle to identify novel protein targets that interact with LRRK2 in its GDP- or GTP-
bound states (Aim 2.2). Our studies will provide critical mechanistic insight into how GTPase and kinase activity
regulate LRRK2-mediated neurodegeneration, and will be important for therapeutic discovery efforts for PD.

Public health relevance
Project Narrative Mutations in the leucine-rich repeat kinase 2 (LRRK2) gene are a common cause of autosomal dominant, familial Parkinson's disease (PD) and the LRRK2 gene contributes to the risk of sporadic PD. Our studies aim to explore novel mechanisms by which mutant forms of LRRK2 lead to neuronal damage in cultured neurons and rat models of PD by elucidating the contribution of enzymatic activity. These studies will have important implications for understanding the molecular pathophysiology of LRRK2-associated PD and for therapeutic drug discovery.